Administrative Core

This Administrative Core will coordinate the overall operation of the UMMS CTRHIB and operate its Educational Component. The specific functions of the Core will be: - To coordinate scientific and technical exchanges between the individual Components of the CTRHIB (Research Projects, Technology Development Project, and Core facilities). - To coordinate quality control and inventory of data and reagents generated in the individual Components and sharing of data and resources with the outside research community - To organize workshops for UMMS and outside investigators on topics relevant to human immunology and biodefense pathogens - To coordinate periodic internal and external review of the research program - To coordinate interactions with NIAID

Public health relevance
The Administrative Core will play a critical role in the overall operation of the UMMS Center for Translational Research on Human Immunology and Biodefense through coordinating the scientific effort across the different projects and obtaining periodic independent review of the program. The Core will also direct the Center's educational programs for the research community